Plasma-initiated Cross-linked Nanocoatings asAnti-infection Agents

PROJECT SUMMARY
Last year in the United States there were more than 1.9 million medical-device-associated infections resulting
in approximately 98,000 deaths. Antibiotic-resistant biofilm-forming bacteria create many problems in medicine
and have detrimental implications for public health. To tackle this problem, “smart” antibiotic-free, anti-infection
cross-linked nanocoatings (sCLNs) designed specifically for catheters have been developed. We have used
argon plasma technology for the construction of sCLNs. These smart nanocoatings consist of acrylic acid
polymer brushes that are cross-linked to silver nanoparticles (AgNPs) in a layer-by-layer fashion with an AgNP
concentration of 2.46 µg/cm2. This was achieved by using a plasma-initiated “grafting-from” approach, coupled
with in situ argon plasma-assisted reduction. These biocompatible anti-infection nanocoatings can sense and
target bacteria and biofilms effectively and specifically. Mechanistic studies involving sCLNs demonstrate
complex activity, triggered by adherent bacteria and biofilms, rather than mere sustained antimicrobial release.
We propose that our sCLNs may be the future for the prevention of medical implant contaminations. Preliminary
data suggest that sCLNs are efficacious for eradicating antibiotic-resistant, biofilm-forming bacteria including
methicillin-resistant Staphylococcus aureus, Staphylococcus epidermidis, and Escherichia coli on biomaterials
used to make catheters. Several potential advantages of sCLNs, compared to traditional surfaces loaded with
antibacterial agents, are their (1) broad activity against antibiotic-resistant bacteria, (2) ability to reduce bacterial
adhesion, (3) rare provocation of bacterial resistance, (4) longevity, (5) specificity, (6) biocompatibility, and (7)
stability.
Three integrated specific aims are proposed to test the hypothesis that sCLNs can be constructed using
plasma technology and are effective at preventing bacterial biofilms in a medically relevant environment. In
Specific Aim 1, experimental variables will be explored to construct stable sCLNs with increased sensitivity to
biofilm formation. In Specific Aim 2, the anti-infective efficacy of sCLNs will be evaluated against several different
gram-positive and gram-negative biofilm-forming strains of bacteria in vitro, under both stationary and
microfluidic cultivation conditions, specifically to model the actual environment of catheters. An exploration of the
mechanism of action with a focus on the induction of bacterial cell lysis in complex biological systems will be
studied by using various viability assays. In Specific Aim 3, the first two aims will be augmented by evaluating
the in vitro safety of sCLNs for human tissue cells in bacterial co-culture. This research seeks to improve upon
existing techniques for the eradication of infections associated with medical and biomedical devices. This work
and program funding will also enhance the research program at Fairleigh Dickinson University by providing
students with opportunities to apply theoretical knowledge to practical, real-world scientific applications.

Public health relevance
NARRATIVE Despite valiant efforts for infection prevention and treatment with antibiotics or surface coatings of antimicrobial cocktails, the number of infections associated with medical devices has increased drastically due to the emergence of resistant bacteria. Current failing approaches can only exacerbate the emergence and spread of antibiotic-resistance, but have led our group to develop antibiotic-free, anti-infection cross-linked nanocoatings as viable surface modifications with great potential to dramatically improve quality of life for people who now suffer dire contamination complications.